Impact of Species-Specific Synaptic Maturation Timing on Cortical Circuit and Behavioral Development

PROJECT SUMMARY/ABSTRACT
Synaptic development in the human brain is strikingly prolonged. This extended developmental timing has been
hypothesized to contribute to the uniqueness of the human brain, explaining some of our extraordinary capacity
for complex thinking but also our propensity for neuropsychiatric disease. Until recently though, testing the
functional impact of synaptic neoteny was limited, as the molecular mechanisms underlying this phenomenon
were largely unknown. A molecular candidate is Slit-Robo Rho-GTPase activating protein 2A (SRGAP2A) that
is found in the genome of all mammals and has undergone two large segmental gene duplications that encode
SRGAP2B and SRGAP2C in humans only. The ancestral gene, SRGAP2A, encodes a postsynaptic protein that
promotes the rate of excitatory and inhibitory synapse maturation, while the human-specific SRGAP2B/C inhibit
all known functions of SRGAP2A to significantly extend synaptic maturation in mouse and human cortical
pyramidal neurons (CPNs). Disrupted timing of synaptic maturation has been associated with diseases such as
intellectual disability (ID), for example, with haploinsufficiency in the Synaptic GTPase Activating Protein 1
(SynGAP1) gene. SynGAP1 encodes for a post-synaptic protein that exerts a function opposite to SRGAP2A by
slowing down the pace of synaptic maturation. Recently, our lab demonstrated that SRGAP2A and SynGAP1
cross-inhibit their postsynaptic accumulation and this cross-inhibition sets the tempo of synaptic maturation in
human and mouse CPNs, demonstrating the need to study ID mutations in the context of human-specific genetic
modifiers. These genetic manipulations in which the timing of excitatory synaptic maturation can be accelerated
(SynGAP1+/-), prolonged (SRGAP2+/-), or rescued (SRGAP2+/-; SynGAP1+/-) provide a unique opportunity to test
the functional impacts of changing the timing of synaptic maturation on the timing of circuit and behavioral
maturation. Aim 1 will utilize CRISPR/Cas9 knock-in approaches and electrophysiology to further characterize
the morphological and functional maturation of excitatory and inhibitory synaptic maturation in these mice. Aim
2 will determine how the timing of synaptic maturation impacts cortical circuit maturation by measuring the timing
of neuronal activity desynchronization using in vivo two-photon Ca2+ imaging. Finally, Aim 3 will evaluate the
effect of synaptic maturation timing on the temporal emergence of adult-like behavioral repertoires using an
unbiased approach called Motion Sequencing. The proposed studies will provide critical insights into our
understanding of human-specific synaptic neoteny and its consequences on the phenotypic expression of
neurodevelopmental disorders uniquely affecting humans.

Public health relevance
PROJECT NARRATIVE Synaptic development in the human brain is strikingly prolonged compared to other mammals, and in humans, this may contribute both to extended periods of learning and increased susceptibility to neurodevelopmental disease. However, the true biological significance and impact of this extended timing on circuit and behavioral maturation is largely unknown. This project will investigate the impact of synaptic developmental timing on the formation of cortical circuits and adult behavior, and this will present a potential novel approach to prevent disease through therapeutic modulation of neurodevelopmental timing.